Support for the 8th Symposium on Harmful Algae in the US

Project Abstract This proposal is to support student, postdoc and manager travel to the 8th Symposium on Harmful Algae in the United States. The symposium is intended to provide a forum for scientific exchange and technical communication on all aspects of HAB research in the United States and will cover a wide range of topics including HAB monitoring and mitigation, event response, human and animal health impacts, toxins and toxin detection, fisheries and food webs, emerging technologies and methodologies for toxin and bloom detection, bloom prediction, forecasting and modeling and a special session on Diarrheic Shellfish Poisoning.

Public health relevance
8th Symposium on Harmful Algae in the United States- Public Health Relevance Harmful algal blooms are a public health concern nationwide in both marine and fresh waters. In some HAB species, the human health impacts are well identified and require rigorous monitoring programs to assure public safety. In other HABs, the human health impacts are poorly understood and need further research to understand the populations at risk and the illness vectors.